Collagen-derived peptides to target inflammation in myocardial infarction

PROJECT SUMMARY
Myocardial infarction (MI) leads to the generation of a scar that is mostly constituted by cardiac extracellular
matrix (ECM). The balance between degradation and deposition of ECM is a strong predictor of clinical
outcomes. ECM degradation occurs by matrix metalloproteinases (MMPs); and ECM deposition occurs by
cardiac fibroblasts. Both ECM degradation and deposition promote adverse remodeling and progression to heart
failure. Within the MMP family, MMP-9 has been reported as a prognostic indicator of cardiac dysfunction in
myocardial infarction (MI) patients; as MMP-9 levels directly associate with patient mortality. Thus, the advantage
of inhibiting MMP-9 after MI has been long recognized. However, clinical trials using global MMP-9 inhibition
have mostly failed both due to lack of MMP inhibitor specificity and importance of MMP-9 in several essential
processes.
We recently identified an ECM-derived peptide (p1159) that acts as a competitive and specific MMP-9 substrate.
Herein, we propose use of p1159 to modulate MMP-9 cleavage of native substrates post-MI. This approach does
not inhibit MMP-9 activity, allowing it to participate in essential processes; instead, it modulates MMP-9
proteolytic capacity to reduce cleavage of endogenous substrates that promote inflammation and inhibit repair.
The synthetic peptide p1159 is a mimetic of the naturally formed fragment C-1158/59 generated by MMP-9
cleavage of collagen post-MI. In humans, plasma levels of endogenous C-1158/59 post-MI correlate with lower
left ventricle filling pressure, indicating a therapeutic potential of C-1158/59. Indeed, mice treated with exogenous
p1159 post-MI display less LV dilation, reduced inflammation and fibrosis, and improved cardiac function. In
vitro, we identified integrin α4 (Itga4) as a peptide receptor. While we know that exogenous delivery is beneficial,
how p1159 regulates post-MI inflammation and ECM deposition has not been mechanistically dissected.
Accordingly, the central hypothesis of this proposal is that p1159 blunts adverse remodeling after MI by serving
as a competitive substrate to reduce MMP-9 proteolysis of substrates necessary for promotion of inflammation
and ECM deposition. To elucidate the mode-of-action and signaling pathways mediated by p1159 in the post-MI
setting, we will use cell-specific Itga4 transgenic animals to identify the mechanisms whereby p1159 tempers
the post-MI inflammatory response, modulates cardiac fibroblast signaling to reduce ECM secretion; and
promotes macrophage-fibroblast crosstalk.

Public health relevance
Project Narrative Despite current therapies, the 5-year mortality after myocardial infarction (MI, commonly known as heart attack) is 40% due to persistent tissue degradation that leads to adverse remodeling of the left ventricle (LV). We developed a peptide that modulates tissue degradation by proteases; this peptide significantly reduces adverse remodeling post-MI by changing the inflammatory profile and directly interacting with reparative cells. This proposal will study the mechanisms underlying the peptide mode of action to explore new therapeutic avenues and, therefore, enhance our fundamental knowledge on the mechanisms of adverse LV remodeling.